Strengthening Text-based Warning Labels on Cannabis Edible Packages

ABSTRACT
Following the commercialization of recreational cannabis in over 20 states, the prevalence of use of non-
combustible cannabis products, such as cannabis-infused edibles, has rapidly increased with unique health
risks and policy challenges. Tobacco and food literature consistently suggests that strengthening warning
labels is an effective way to communicate health risks and modify perceptions and behaviors. Although all
recreational cannabis legalized states require warning labels, most opt for text-only, lengthy, composite
messages placed in small labels on the back of the package. Tobacco literature has demonstrated that such
inconspicuous messaging has little effect. The impact of warning labels is further complicated by package
styles, with youth-appealing packaging commonly observed in the U.S. and plain packaging required in
Canada. Empirical research on the effective design of text-based warning labels and their interactions with
package styles is lacking in cannabis research. The overarching goal of this project is to investigate the effect
of strengthened text-based warning labels on cannabis edible packaging with diverse styles. We will assess a
range of front-of-package warning label features proposed to reinforce the effectiveness of existing text-based
warnings. These features include presentation characteristics such as enlarged size, contrasting colors,
prominent positioning, an added warning symbol, and message formats, such as rotating multiple short
warning messages. We will examine the effect of these strengthened warning label features compared to
current mandates and how the effect is modified by different package styles, including branded, youth-
appealing, and plain packaging. As observational data are not available, we will adopt innovative experimental
approaches with distinct yet complementary strengths, including eye-tracking experiment, discrete choice
experiment, and full factorial randomized experiment. The project will be carried out in 3 phases. Aim 1 will
conduct an eye-tracking experiment to identify warning label presentation characteristics and associated levels
that increase visual attention, and examine their interactions with different package styles. Aim 2 will conduct a
discrete choice experiment to quantify the effect of attention-grabbing warning label presentation
characteristics identified in Aim 1 on use intentions and willingness-to-pay, and examine how package style
modifies the effect. Aim 3 will conduct a longitudinal, full factorial randomized experiment to quantify the
longitudinal effect of short message rotation and optimal warning presentations identified in Aim 2 on product
appeal, knowledge, harm perceptions, and use intentions, and examine how package style modifies the effect.
The findings of this project are expected to guide policymakers in implementing effective text-based cannabis
warning labels and quantify their potential public health impacts.

Public health relevance
NARRATIVE AND RELEVANCE Tobacco and food literature consistently suggests that strengthening warning labels is an effective way to communicate health risks and modify perceptions and behaviors. The overarching goal of this project is to investigate the effect of strengthened text-based warning labels on cannabis edible packaging with diverse styles. With cannabis legal markets expanding rapidly, the findings of this project are expected to guide policymakers in implementing effective text-based cannabis warning labels and quantify their potential public health impacts.